Project 2: Mitigating Population Differences in Lung Cancer among Native Hawaiians: A Population-Based Approach to Enhance Prevention and Elucidate Lung Tumor Biologyy

We have shown in the MEC Cohort that Native Hawaiians have a markedly higher risk of lung cancer and a poorer survival from the disease compared to Whites, even after accounting for smoking history and other risk/prognostic factors. This excess risk was observed for the two most common histologic cell-types: adenocarcinoma and squamous cell carcinoma as well as for small-cell lung cancer, a more aggressive cell-type. The poorer survival is observed with early stage and not advanced disease. We have made extensive efforts in the study of genetics, epigenetics and smoking and tobacco carcinogens-related biomarkers to understand the differences in lung cancer risk across populations. While the high risk in African Americans and low risk in Japanese Americans can be explained by higher and lower smoking intensity (carcinogens dose per cigarette), due to smoking behavior and lower nicotine metabolism, respectively, reasons for the risk excess in Native Hawaiians remain to be elucidated. Lung cancer screening using low-dose Computed Tomography (LDCT) among adults aged 50 to 80 years who have a 20 pack-year smoking history and currently smoke, or have quit within the past 15 years, has been found to decrease mortality. However, the state of Hawaiʻi ranks last in the proportion of lung cancers diagnosed at an early stage (19% vs. the national average of 24%), with less than 3% of high-risk smokers undergoing LDCT scan (national average is 6%). Studies have suggested that the use of risk-based prediction models may be more effective than the U.S. Preventive Services Task Force (USPSTF) criteria at identifying high-risk smokers for lung cancer screening. However, both the USPSTF guidelines and these risk prediction models were derived from data collected in mostly European-descent populations. We also found that there may be distinct biological processes related to tumorigenicity that contribute to the excess risk and poor disease outcomes for Native Hawaiians. We observed differences in epigenetic patterns in blood leukocyte DNA associated with smoking dose in Native Hawaiians when compared to other populations, with the differential methylation occurring in cancer-related genes. To reduce the lung cancer burden of Native Hawaiians, we propose a multilevel translational study to identify the individual- and provider-based obstacles for lung cancer screening to develop an intervention strategy to be disseminated in collaboration with the Hawaiʻi Department of Health (Aim 1), to better identify those at greatest risk of developing lung cancer by computing a Native Hawaiian-specific risk prediction model (Aim 2), and to characterize the tumor pathobiology associated with the poor survival of Native Hawaiian lung cancer patients (Aim 3). Study findings will provide critical information along the range of lung cancer healthcare services for a high risk population. During this grant cycle, we will develop collaborations to translate our findings into validated population-tailored, precision-based interventions to increase early detection and efficacy of treatment modalities in this high-risk population.

Public health relevance
Native Hawaiian smokers experience one of the highest population-level risk of lung cancer, which is not fully explained by their smoking history. This multilevel translational study aims to identify obstacles to lung cancer screening in Native Hawaiians, construct a population-specific risk prediction model to enhance screening guidelines, and molecularly profile lung tumors from Native Hawaiian patients to characterize the biological mechanisms that contribute to their high risk and poor survival. Study findings will help design a culturally informed health education campaign to improve lung cancer screening utilization and provide information towards more tailored precision-based treatment strategies for this high risk population.